Total Neoadjuvant Therapy (TNT) for Borderline Resectable and Locally Advanced Pancreatic Adenocarcinoma

PROJECT SUMMARY/ABSTRACT – RP1
Surgery is the only potentially curative treatment for patients with pancreatic ductal adenocarcinoma (PDAC) but
is available to only <20% of patients. For the 20%-30% of patients with borderline resectable or locally advanced
(BR/LA; involving major abdominal vasculature) PDAC, neoadjuvant therapy with induction chemotherapy, with
or without radiotherapy, is the emerging standard. This sequence with chemotherapy up-front provides the
opportunity to downstage tumors to allow curative resection. Importantly, early treatment of micrometastatic
disease helps select patients who are likely to benefit from surgery and spares unnecessary surgery in those
who would not benefit.
Evidence to date supports neoadjuvant therapy, but a more-structured, comprehensive approach is needed,
which requires rigorous prospective evaluation. Moreover, there are currently no biomarkers that reliably predict
treatment response or resistance. This knowledge is essential to appropriately select patients who will benefit
from specific treatment regimens and to modulate treatment for individual patients.
We will evaluate the efficacy of total neoadjuvant therapy (TNT) combining novel triplet chemotherapy with
ablative-dose radiotherapy (AD-XRT), given before surgery, in a phase II trial (Aim 1). This trial will assess the
promising 5-fluorouracil/leucovorin + liposomal-irinotecan + oxaliplatin (NALIRIFOX) regimen, administered
entirely up-front for 4 months, followed by AD-XRT (biological equivalent dose of 100 Gy, delivered in 15-25
fractions, with capecitabine as radiosensitizer). The primary endpoint is event-free survival, with events defined
as progression, recurrence after surgery, or death.
Toward the development of biomarkers of treatment response after TNT, we will assess the potential of (Aim
2A) radiomics analysis of CT images and (Aim 2B) functional FDG-PET and novel immunoPET using 89Zr-
HuMab-5B1 that recognizes cancer antigen 19-9 (CA19-9) to monitor treatment response, assess surgical
resectability, and predict survival. Using blood samples collected on the trial, we will also evaluate circulating
tumor DNA (measured by MSK-ACCESS targeted sequencing) and serum CA19-9 for the same purpose (Aim
3).
This clinical trial aims to define TNT as a new treatment standard for BR/LA PDAC. The planned correlative
studies promise to identify noninvasive biomarkers of response after TNT that may be rapidly translated to the
clinic to allow adaptive disease management. As patients with BR/LA PDAC stand to benefit greatly from
improvements in treatment and monitoring, because of the opportunity to enable curative resection, this project
will likely have a major impact on outcomes in PDAC overall.

Public health relevance
PROJECT NARRATIVE – RP1 To address the need for more-effective treatment strategies for patients with borderline or locally advanced pancreatic cancer, we will conduct a phase II clinical trial to evaluate the efficacy of total neoadjuvant therapy with novel triplet chemotherapy followed by ablative-dose chemoradiotherapy (designed to destroy the primary tumor), given before surgery. To address the urgent need to identify biomarkers of treatment response, we will assess the potential for advanced imaging with computational analysis of CT images, functional imaging with FDG-PET, and immunoPET using a targeted agent that recognizes a specific tumor marker, as well as blood- based circulating tumor DNA to detect response to treatment, assess resectability, and predict survival. If these noninvasive biomarkers prove to be informative, they will allow customized tailoring of treatment for individual patients.